Impact of Pregnancy, Obesity, and Vitamin D Binding Protein on Vitamin D Kinetics

PROJECT SUMMARY
Nearly one-third of US reproductive aged women have obesity prior to pregnancy and similar numbers have
vitamin D insufficiency (25(OH)D< 20 ng/mL). Both vitamin D deficiency and obesity may impact the
intrauterine and maternal environment to increase the risk of adverse birth outcomes. Risk of obesity and D
deficiency are significantly higher among Black women compared to White women. In addition, well-described
differences in vitamin D metabolites, calcitropic hormones, and vitamin D binding protein (DBP) genotype are
evident in Black women compared to White women. Despite a dramatic increase in awareness of the multiple
roles of vitamin D in human health, little is known about regulation of vitamin D metabolism during pregnancy.
Maternal concentrations of the prohormone 25(OH)D remain constant across pregnancy but concentrations of
the hormone calcitriol (1,25(OH)2D) more than double in early pregnancy and, despite the rapid t1/2 of calcitriol
(~4 h), this hormone remains elevated across the 9-month gestation period. These changes are unique to
pregnancy and do not occur at any other life stage. Marked metabolic changes in D absorption and/or
utilization must occur to support these physiological changes, but these pathways remain largely unexplored at
this key life stage. Obesity increases the risk of vitamin D deficiency but it is unknown if this is due to
sequestration in body fat, obesity-driven changes in the hormone activation or inactivation pathways, or to
other unidentified differences in D absorption and utilization. We recently developed a novel ultra-high
performance liquid chromatography tandem mass spectrometry method capable of measuring the absorption
of trideuterated-vitamin D3, its conversion into 25(OH)D3 and the subsequent serum half-life of 25(OH)D3. We
will use this innovative approach to examine vitamin D kinetics in non-pregnant and pregnant women. This
approach allows us for the first time in humans, to evaluate metabolic utilization of vitamin D3 and how it
is impacted by pregnancy (Aim 1). Genetic variants in the DBP gene that affect DBP concentration, as well
as genetic variants in other key genes that are directly involved in vitamin D3 and 25(OH)D3 production and
utilization, and their contribution to the differences in vitamin D kinetics will be characterized between White
women and Black women whose genetic ancestry will be confirmed with ancestry-informative genetic markers
(Aim 2). The impact of adiposity on outcomes will be addressed by recruiting both normal weight women and
women with obesity in each ancestry group. Body composition will be measured, and subcutaneous abdominal
fat will be collected to 1) evaluate how this storage depot of vitamin D3 and 25(OH)D3 is impacted by obesity,
genetic ancestry, and pregnancy and 2) determine how variability in the mass of this storage depot impacts D
kinetics (Aim 3). The proposed research will provide novel data on the maternal metabolic pathways that
impact vitamin D utilization and will identify both modifiable and non-modifiable factors that can be targeted to
improve maternal vitamin D status and fetal vitamin D availability across pregnancy.

Public health relevance
PROJECT NARRATIVE The 2020 Dietary Guidelines have highlighted vitamin D as a nutrient of concern; increased risk of vitamin D3 deficiency is observed in Black individuals, individuals with obesity and in pregnant women. The proposed project will use an innovative, trideuterated vitamin D3 approach to obtain the first kinetic data on D3 and 25(OH)D3 dynamics in non-pregnant and pregnant White women and Black women with and without obesity. Findings obtained will identify non-modifiable (genetic ancestry and functional consequences of vitamin D metabolism genes) and modifiable factors (maternal vitamin D status and BMI) that influence vitamin D utilization across gestation.